The Role of Müller Glia in Acute and Chronic Response to Stress, Injury, and Disease in the Retina

PROJECT SUMMARY
Tissues respond to stress, injury, and disease through a process called inflammation, which involves
the activation of the immune system, repair of tissues, and removal of cellular debris. Inflammation can
be acute and last for several days or chronic and last for several months to years. In the retina, acute
inflammation is often associated with bacterial or viral infection (e.g., uveitis), and chronic inflammation
occurs in retinal diseases, including age-related macular degeneration, retinitis pigmentosa, and
diabetic retinopathy. Inflammation is often neuroprotective, but under some circumstances, it can
accelerate retinal disease progression and vision loss. Multiple cell types participate in the acute and
chronic inflammatory processes in the eye; these cells include astrocytes, microglia, Müller glia,
immune cells, vascular endothelial cells, and retinal pigment epithelia. For simplicity, researchers often
focus on a single cell type in a particular disease process (e.g., microglia in age-related macular
degeneration), and they use short-term acute injuries (e.g., light damage or N-methyl-D-aspartate) to
gain insights into chronic inflammation in retinal disease. Thus, a major gap in our knowledge is the role
of each cell type across diverse stress, injury, and disease conditions. To address this gap, we have
spent the last 3 years developing a detailed profile of the acute inflammatory response in human and
mouse retinae to 15 physiologically relevant cellular perturbations; those data are in the Acute Retinal
Stress Interactive Portal (ARS-IP). We have also profiled 12 genetic mouse models of human
retinopathy, and those data are in the murine Retinal Disease Database (mRD-Db). All unpublished
data from the ARS-IP and mRD-Db are freely shared through the St. Jude Cloud. The most exciting
discoveries we have made by integrating the ARS-IP and mRD-Db data are that Müller glia play a
central role in coordinating the inflammatory response and distinct pathways are activated during acute
versus chronic retinal inflammation. Therefore, we are uniquely positioned to investigate the interplay
between acute and chronic inflammation in retinal disease. This proposal is focused on Müller glia, but
we will profile all retinal cell types and share unpublished data through the St. Jude Cloud to accelerate
discoveries in other cell populations that contribute to retinal inflammation. This research proposal is
relevant to human health, as it will provide a deeper understanding of the molecular and cellular
mechanisms that maintain retinal homeostasis and how those mechanisms are disrupted during acute
and chronic disease conditions that are directly relevant to human blindness.

Public health relevance
PROJECT NARRATIVE (Relevance Statement): We have developed the largest fully integrated database that is shared with researchers around the world to help identify the molecular and cellular changes associated with retinal disease. Using this database, we discovered that Müller glia play a central role in maintaining retinal homeostasis and activating distinct pathways that mediate acute versus chronic stress, injury, and disease. Discoveries from this study will advance our understanding of complex cellular mechanisms that are directly relevant to human retinopathies and bridge a fundamental gap in our knowledge about the interplay between acute and chronic responses to disruptions in retinal homeostasis.